Statistical Software for Genetic Association Studies

[unreadable] DESCRIPTION (provided by applicant): Risks of complex diseases, such as cancers, hypertension, diabetes, and schizophrenia, are determined by both genetic and environmental factors. Advances in human genome research have thus led to epidemiologic investigations not only of the effects of genes alone, but also of their ef- fects in combination with environmental exposures. The case-control study design, which has been widely used in classical questionnaire-based epidemiologic studies, is now commonly employed to study the role of genes and gene-environment interactions in the etiology of complex diseases. Recently, a broad class of profile-likelihood semiparametric methods has been developed for the analysis of case-control genetic data in the presence of environmental factors. These methods ex- ploit knowledge about the distribution of the basic genetic information in order to build estimators that are much more statistically efficient than other approaches, and are also statistically valid in the presence of incomplete genetic data, such as missing marker alleles and unphased haplotypes. Because this kind of methodology is not available in any commercial software, researchers have resorted to standard approaches, which lack statistical efficiency and sometimes validity. As a re- sult, important gene-environment interactions are obscured, as are important main effects. The goal of this project is to develop Stata software to implement the profile-likelihood semiparametric methods and related methods. The software will handle missing genotypes, unphased haplotypes, flexible haplotype models with haplotype-environment interactions, and models both with and with- out Hardy-Weinberg equilibrium. This tool will be highly useful to epidemiologists and geneticists in their search for genetic and environmental determinants of complex diseases. Risks of complex diseases, such as cancers, hypertension, diabetes, and schizophrenia, are deter- mined by both genetic and environmental factors. Advances in human genome research have thus led to epidemiologic investigations not only of the effects of genes alone, but also of their effects in combination with environmental exposures. This project will implement new and more efﬁcient statistical methods for the analysis of case-control genetic data in the presence of environmen- tal factors, and thus bring into the mainstream better ways of detecting main genetic effects and gene-environment interactions. [unreadable] [unreadable] [unreadable]